Epithelial-immune interactions in neonates with Spontaneous Intestinal Perforation

Project Summary
Spontaneous intestinal perforation (SIP) is a gastrointestinal complication affecting 3-8% of extremely low birth
weight infants, corresponding to approximately 4,000 prematurely born babies annually in the US. All affected
infants require surgery and are at an increased risk of brain injury, infection, and death. Yet, the pathogenesis
and etiology of SIP are poorly understood. Consequently, there are currently no biomarkers for early recognition
or disease-specific therapy. The foundation for this proposal is preliminary and published data where we showed
alterations in T cell and epithelial cell subsets in SIP-affected mucosa that was not present in non-SIP mucosal
samples. Intestinal immune dysregulation in SIP was characterized by reduced tissue-resident memory T cells,
increased naïve T cells that produce more IFNγ upon stimulation, and a decreased proportion of epithelial cells
in SIP compared to fetal and neonatal controls. This suggests that the inability to generate tissue-resident
memory T cells in utero and the proinflammatory effects of the naïve T cells that infiltrate the intestine in their
place after birth could contribute to the development of SIP. We hypothesize that susceptibility to intestinal
perforation in extremely premature infants is exacerbated by defects in memory T cell generation and
concomitant epithelial cell damage. We will perform a comparative analysis of T cells’ transcriptome and spatial
location in patients with SIP compared to samples from fetal and neonatal mucosa. Using a T cell co-culture
organoid model, we will investigate the impact of aberrant T cell activation and IFNγ exposure on epithelial cells
in healthy and affected mucosa. Completing these aims will provide data to inform a next-step large-scale study
into the role of epithelial-immune dysfunction in SIP.
The candidate is committed to a career in studying epithelial-immune cell interactions using spontaneous
intestinal perforation as a model and is strongly supported by her mentors and her department at the Yale School
of Medicine. The proposal builds upon the candidate’s prior research and clinical experience in immune
dysregulation in neonatal intestinal disease. It integrates two new domains of expertise in epithelial-immune
interactions using organoids and integrative network analysis in a comprehensive training and didactic plan. This
proposal is supported by dedicated and experienced mentors with expertise in mucosal immunology,
immunobiology, T-cell signaling in immune disorders, neonatal nutrition, and biostatistics. The proposed
experiments and didactics will provide the candidate with interdisciplinary skills that will foster her transition to
independence as a physician-scientist in studying epithelial-immune cell interactions in intestinal disorders in
children.

Public health relevance
Project Narrative In the United States, about half a million infants are born prematurely, prior to 37 weeks gestation, annually. Extremely premature infants born before 28 weeks gestation with a birth weight <1000g are most susceptible to complications of preterm birth, including spontaneous intestinal perforation, where little is known about the pathogenesis of this disease, and there are no disease-specific therapies. The proposed research will elucidate how aberrant T-cell activation exacerbates epithelial cell damage in spontaneous intestinal perforation with the hope of providing avenues for future studies into therapeutic targets in at-risk neonates.